Investigating the molecular functions and mechanisms of RNA-binding proteins crucial for gametogenesis

Among couples trying to conceive, 10-15% will be affected by infertility, which can be caused by
impaired gametogenesis. Effective post-transcriptional gene regulation by RNA-binding proteins (RBPs)
is crucial for normal gametogenesis, with mutations in RBPs impairing such regulation and causing
infertility in humans. For example, the Deleted in Azoospermia (DAZ) family of RBPs are essential for
human fertility, because during spermatogenesis they regulate translation of a subset of mRNAs by
binding to their 3′ UTRs; their molecular mechanism of action was understood only after their
Drosophila ortholog was identified and studied genetically. However, the full repertoire of RBPs that are
essential for gametogenesis is currently unknown. To fully understand the complex post-transcriptional
gene regulation during gametogenesis, it is critical to identify novel RBPs that are important for these
processes and elucidate their molecular functions and mechanisms of action.
We have recently identified three previously uncharacterized RBPs (MARF1, Tanenashi, and
CG44249) that are essential for fertility in Drosophila. Our data suggest that MARF1, which is
expressed in oocytes and is required for female fertility, regulates mRNA poly-A tail length during
oogenesis. Tanenashi, which is expressed in spermatocytes and is required for male fertility, plays
roles in promoting the expression and splicing of male fertility factor genes containing mega-base-sized
introns with highly repetitive DNA sequence on the Y chromosome during spermatogenesis. CG44249,
which is expressed in ovaries and is required for female fertility, likely plays a role in splicing regulation
during oogenesis. We also showed that a fourth RBP (Loqs-PB), which is important for female fertility
and germline stem cell maintenance in ovaries, regulates the length of microRNAs in ovaries. These
four RBPs are conserved from flies to humans.
Using Drosophila, I now propose to further investigate these four RBPs, and determine their
precise molecular functions and mechanisms of action in gametogenesis. By investigating mutant flies
in vivo and the proteins in vitro, we will test our hypothesis that: (i) these RBPs each bind specific target
RNAs by recognizing specific RNA sequence and/or structure motifs, and (ii) thereby promote or inhibit
the processing of bound RNAs at specific molecular steps, allowing highly regulated spatiotemporal
expression of targeted genes during gametogenesis.
These studies will advance our fundamental knowledge of the molecular mechanisms of post-
transcriptional regulation of gene expression, especially by regulating the mRNA poly-A tail length,
mRNA splicing, and microRNA length, during gametogenesis, providing potential for improved
diagnosis and treatment of human infertility.

Public health relevance
Project Narrative Infertility, which affects 10-15% of couples, can be caused by impaired egg and/or sperm production (gametogenesis). There remain key limits to our understanding of the gametogenesis processes, especially how sophisticated gene expression programs operate during these processes, impeding fundamental science and the diagnosis and treatment of infertility. To address these limits of knowledge we will build upon our discoveries of previously uncharacterized RNA-binding proteins that are crucial for gametogenesis, to now elucidate their molecular functions and mechanisms of action in the gene expression programs during gametogenesis.